UVB radiation-generated microvesicle particles as effectors for photosensitivity

Abstract
Ultraviolet B (UVB) radiation has profound effects upon skin and generates systemic consequences from fever
to immunosuppression to vitamin D production. As UVB only penetrates the epidermis, a major unanswered
question in photobiology is how UVB-treated epidermal skin sends systemic signals. Recent studies have
indicated that small membrane-bound vesicles known as microvesicle particles (MVP) released from cells in
response to various stressors can act as potent signaling agents due to their ability to carry nuclear and
cytoplasmic components. We have demonstrated that UVB generates MVP release from epithelial cells and
skin, which could provide a potential mechanism for UVB-mediated systemic signaling. Our group and others
have demonstrated that UVB radiation generates high levels of the lipid mediator Platelet-activating factor
(PAF) produced enzymatically and PAF-receptor (PAFR) agonists produced non-enzymatically via reactive
oxygen species. Our ongoing studies using antioxidants and PAFR-expressing/null cell lines and
pharmacologic/genetic inhibition of the enzyme acid sphingomyelinase (aSMase) have implicated involvement
of PAFR signaling resulting in aSMase activation in UVB generated MVP (UVB-MVP). Finally, we provide
evidence that UVB-MVP do not carry significant amounts of protein cytokines, yet carry bioactive PAF
agonists. We have evidence that metabolically labile PAF agonists are protected traveling in MVP and these
bioactive lipids are involved in acute pro-inflammatory and delayed immunosuppressive effects of UVB. Yet
knowledge gaps exist as to how UVB-MVP are generated and if this new pathway can be exploited to treat
photosensitivity diseases. Two aims are designed to test the hypothesis that UVB generates MVP in human
skin in a PAF-dependent manner involving aSMase and transfers both local and systemic effects via their
carried PAF agonists. Aim 1 will use in vitro cell lines and murine genetic and pharmacologic models to
determine the mechanisms of UVB-MVP generation. This aim will validate tools to define the roles of UVB-
MVP in acute pro-inflammatory effects of UVB, using a murine model of photosensitivity that we have
previously demonstrated is PAF-dependent and a separate photosensitive murine lupus model. Aim 2 will use
both ex vivo skin explants and in vivo human subjects to test the ability of human skin to generate UVB-MVP.
Moreover, we will define if oral antioxidants and topical aSMase inhibitor treatments will block UVB-MVP
generation and UVB-mediated acute inflammation in humans. Finally, we will test if human subjects exhibiting
clinical photosensitivity respond to UVB with increased UVB-MVP and if a topical aSMase inhibitor blocks the
UVB-MVP and the exaggerated skin reactions. Successful completion of this project will (i) address an
important question in photobiology as to how a keratinocyte-specific stimulus can generate systemic signaling
effects, (ii) offer pharmacologic mechanisms to block UVB local and systemic effects. These studies also have
implications for understanding the effects of other pro-oxidative stressors including ionizing radiation.

Public health relevance
Project Narrative A major question in photobiology is how ultraviolet B radiation (UVB)-treated skin sends systemic signals. This project applies multiple well-established techniques and approaches at clinical, cellular and molecular levels to investigate the involvement of the lipid mediator Platelet-activating factor in UVB-induced microvesicle particle release which could be the transmitter for systemic signaling effects. These studies have significant therapeutic implications and will provide novel insights and targets into processes from photosensitivity disorders to medical phototherapy.